Activated NK CAR Cells to Cure HIV

ABSTRACT Virus-specific CD8 T cells exert antiviral activity against HIV-1/SIV in vitro and in vivo. Yet, despite
these responses in HIV-1-infected humans and SIV- infected macaques, they are unable to fully suppress virus
replication. This is likely due to the majority viral replication occurring in CD4+ T cells within B-cell follicles in
secondary lymphoid tissues; where virus-specific CD8 T cells are relatively few in number. In fact, we found that
in vivo effector virus-specific CD8 T cell to target SIV RNA+ cell ratios (E:T) were over 40-fold lower inside
compared to outside of B cell follicles in lymphoid tissues. These findings indicate that B cell follicles are an
immune privileged site in which low levels of virus-specific CD8 T cells permit ongoing viral replication.
Furthermore, we found that few virus-specific CD8 T cells express the follicular homing molecule CXCR5, likely
explaining their low levels in B cell follicles. These data suggest that the inability of virus specific CD8 T cells to
fully suppress virus replication may be due to a deficiency of these T cells in B-cell follicles. These findings have
led us to our central hypothesis that targeting HIV-specific immunotherapy to B cell follicles will lead to durable
remission of HIV infection. In support of this hypothesis we have shown that increased levels of virus-specific
CD8 T cells in B cell follicles is associated with lower viral loads. Although many immunotherapies utilize patient
T cells to generate CAR-T therapies, there are special consideration in the treatment of HIV. One major short
comings of CAR-T approaches is the fact that T cells need to be autologous due to the risk of graft versus host
disease (GvHD), requiring complicated/expensive manufacturing processes of patient cells. This is also
challenging in the HIV setting as the patient T cells are already compromised and processing cells which may
contain active virus is risky. Alternatively, Natural Killer (NK) cells are highly suited for allogeneic use as they do
not cause GvHD and thus hold significant clinical potential as an off-the-shelf cellular product. Thuts, we propose
to evaluate NK immunotherapy that targets virus-specific CAR NK cells (expressing CD4-MBL-CAR and CXCR5)
to B cell follicles. Moreover, we will use CRISPR/Cas9 to knockout negative regulators of NK cell function, such
as PD1, which we have previously shown to enhance NK cell function. Our long-term goal is to develop an
intervention that will lead to durable remission of HIV infection using CAR NK cells. To test our hypotheses, we
propose the following aims. 1) Develop reagents and methods to generate human and rhesus macaque
CAR/CXCR5/PD1KO NK cells. 2) Determine the ability of CAR/CXCR5/PD1KO NK cells to migrate into B cell
follicles of SIV-infected rhesus macaques and to induce and maintain viral suppression. Our proposed studies
targeting CAR NK cells to follicles will have a broad impact on the field by providing insights into cell trafficking,
persistence, and pre-conditioning regimens for NK immunotherapy. Moreover, our methods for engineering
rhesus macaque NK cells will enable studies assessing the therapeutic use of NK cells in preclinical NHP models.
Moreover, these studies could result in an effective strategy to induce long-term sustained remission of HIV.

Public health relevance
PUBLIC HEALTH RELAVENCE There is a need to develop improved treatments for HIV patients. The studies proposed here will evaluate a novel treatment strategy that uses NK cells to target a reservoir of HIV within lymphoid tissues. This therapy has the potential to achieve durable suppression of HIV.